Synphilin-1 and Obesity

DESCRIPTION (provided by applicant): Obesity is the most common metabolic disease, resulting from the ingestion of calories in excess of ongoing requirements. Increased prevalence of obesity has resulted in rapidly accelerating rates of obesity related disorders such as type 2 diabetes and cardiovascular disease. The pathogenesis of obesity remains incompletely understood. In the current application, we propose to investigate a novel role for synphilin-1 in food intake and body weight control. Synphilin-1, a cytoplasmic protein, interacts with alpha-synuclein and parkin and has implications in Parkinson's disease pathogenesis related to protein aggregation. Through work examining the phenotype of a synphillin-1 transgenic mouse (SP1), we have evidence that synphilin-1 over- expression significantly increases body weight and does so through increasing food intake. We have found that synphilin-1 is highly expressed in neurons of hypothalamic nuclei involved in energy balance, suggesting that synphilin-1 may be affecting energy balance by modulating hypothalamic signaling. Our preliminary data suggest that synphilin-1 may affect food intake and body weight through increases in orexigenic genes: NPY and AgRP expression in hypothalamic neurons. Recently, studies have suggested that AMP-activated kinase (AMPK) is a central neuronal energy sensor that plays a major role in maintaining energy homeostasis. Our preliminary data showed that expression of human synphilin-1 increased AMPK phosphorylation in cultured N1E-115 cells and at the PVN site, and further showed that synphilin-1 interacted with AMPK as indicated by co-immunoprecipitation. Thus, in this proposal, we will test the hypothesis that synphilin-1 modulates hypothalamic feeding related gene expression and AMPK signaling cascades resulting in hyperphagia and obesity. In Aim 1, we will characterize changes in food intake, body weight and patterns of hypothalamic gene expression in responses to overexpression of synphilin-1. We will specifically assess the bases for the increased meal size that characterizes the hyperphagia in SP1 mice by testing responses to central and peripheral peptide administration and characterizing their taste preferences. In Aim 2, we will investigate the role of endogenous hypothalamic synphilin-1 in response to alterations in metabolic status. In Aim 3, we will test the hypothesis that synphilin-1 alters AMPK signaling cascades and its related cell energy events in an in vitro cell culture system. In Aim 4, we will test the hypothesis that synphilin-1 activates AMPK signaling in hypothalamus resulting in hyperphagia and obesity in vivo using overexpression and siRNA knockdown approaches. These studies will provide insight into the molecular mechanisms underlying synphilin-1-induced hyperphagia and obesity, will enlarge our knowledge of the biological functions of synphilin-1, and may provide a unique genetic obesity model for future studies of the pathogenesis of obesity.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to investigate the role and the molecular mechanisms of synphilin-1 protein in regulating food intake and body weight using behavioral, pharmacological and cell biological approaches. These studies will greatly increase our understanding of the biological functions of synphilin-1 and will provide new insights into the molecular mechanisms underlying obesity and related disorders. Project Narrative: We propose to investigate the role and the molecular mechanisms of synphilin-1 protein in regulating food intake and body weight using behavioral, pharmacological and cell biological approaches. These studies will greatly increase our understanding of the biological functions of synphilin-1 and will provide new insights into the molecular mechanisms underlying obesity and related disorders. __SpecificAimsTextDelimiter__ Specific Aims: The long-term goals of our research are the elucidation of the pathogenesis of obesity and the discovery of potential therapeutics for intervention. Obesity is the most common metabolic disease and results from ingesting calories in excess of ongoing requirements. Increased prevalence of obesity has resulted in rapidly accelerating rates of obesity related disorders such as type 2 diabetes and cardiovascular disease (10- 13). The pathogenesis of obesity remains incompletely understood. Synphilin-1 has previously been demonstrated to interact with alpha-synuclein and parkin, and has been implicated in Parkinson's disease pathogenesis related to protein aggregation (14-18). We and others demonstrate that synphilin-1 is expressed predominantly in the cytosol in many tissues, with enriched expression in neurons (16,19-21). By examining the phenotype of a synphillin-1 transgenic mouse (SP1), we have evidence that overexpression of synphilin-1 significantly increases body weight and does so through increasing food intake. We further found that synphilin-1 is highly expressed in the cytosol of neurons in the arcuate (ARC) and paraventricular (PVN) nuclei that have critical role in energy balance. Alteration of hypothalamic orexigenic and anorexigenic gene expression in feeding-related peptides and peptide receptors has been shown to affect food intake and energy balance (12,13,22-27). Our preliminary data showed that SP1 mice that were pair fed to the intake of the non-transgenic control mice displayed the same body weight as non transgenic mice, but had significantly increased hypothalamic expression of the orexigenic genes: NPY and AgRP. These results suggest that synphilin-1 is involved in regulating gene expression of feeding-related peptides. AMP-activatedkinase (AMPK) is a central neuronal energy sensor that plays a major role in maintaining energy homeostasis (28-31). In the hypothalamus, AMPK has been proposed to be a master regulator of food intake by integrating hormonal and nutrient signals (32). A decrease in hypothalamic AMPK activity is associated with decreased feeding, whereas activation of AMPK leads to increased food intake. In normal physiological condition, fasting increases AMPK activity in the hypothalamus, while refeeding suppresses it (32,33). Our preliminary data showed that expression of human synphilin-1 increased AMPK phosphorylation (activation) in cultured N1E-115 cells and at the PVN site, and that synphilin-1 interacted with AMPK by co- immunoprecipitation studies. These data suggest functional interaction between these two proteins affecting food intake and body weight. Thus, the goal of this proposal is to test the hypothesis that synphilin-1 modulates hypothalamic feeding related gene expression and AMPK signaling cascades resulting in hyperphagia and obesity. This goal will be achieved via the following specific aims: Aim 1: Characterize changes in food intake, body weight and patterns of hypothalamic gene expression in responses to overexpression of synphilin-1. We will specifically assess the bases for the increased meal size that characterizes the hyperphagia in SP1 mice by testing responses to central and peripheral peptide administration and characterizing their taste preferences. Aim 2: Investigate the role of endogenous hypothalamic synphilin-1 in response to alterations in metabolic status. Aim 3: Test the hypothesis that synphilin-1 alters AMPK signaling cascades and its related cell energy events in an in vitro cell culture system. Aim 4: Test the hypothesis that synphilin-1 activates AMPK signaling in hypothalamic neurons resulting in hyperphagia and obesity in mice. Significance: These studies will investigate the role of synphilin-1 in food intake and body weight control, will provide insight into the molecular mechanisms underlying synphilin-1-induced hyperphagia and obesity, will increase our knowledge of the biological functions of synphilin-1, and may provide a unique genetic obesity model for future studies of the pathogenesis of obesity. The outcomes from the proposed studies will represent a significant advance towards the long-term goal of understanding the biological functions of synphilin-1 and the mechanisms underlying food intake related disorders and obesity pathogenesis.